Engineering a Microphysiological System to Model the Infarct Border Zone and Interrogate Oxygen-Dependent Cell-Cell Communication in the Myocardium

PROJECT SUMMARY/ABSTRACT
Myocardial infarctions are caused by coronary artery occlusions that acutely deprive a localized region
of myocardium of oxygenated blood, resulting in a steep oxygen gradient at the infarct border zone. Infarcted
tissue then progresses through a pro-inflammatory phase of wound healing, followed by an anti-inflammatory,
pro-fibrotic phase. However, for reasons that are poorly understood, the infarct border zone often undergoes
adverse remodeling that does not resolve, leading to pathologies such as prolonged inflammation, fibrosis,
arrhythmias, pathological hypertrophy, and heart failure. Cardiomyocytes, macrophages, and fibroblasts are
each key components of the myocardium and are known to regulate each other. However, how an oxygen
gradient (a defining feature of the infarct border zone) impacts crosstalk between these three cell types and
downstream remodeling is poorly understood, largely due to limitations of existing model systems. During the
first funding period of this R01, we engineered innovative “Myocardial Infarct on a Chip” devices that enabled
us to co-culture hypoxic and normoxic cardiomyocytes and/or fibroblasts, which led to the new discovery that
hypoxic-normoxic crosstalk had a detrimental effect on cardiomyocyte physiology and heightened pro-
inflammatory signaling in both cell types compared to uniform normoxia and uniform hypoxia. Building on these
results, our new goal is to test the hypothesis that oxygen-dependent crosstalk between cardiomyocytes,
fibroblasts, and macrophages is a driving factor of pathological remodeling after myocardial infarction. To test
this hypothesis, we will use devices that we developed during the first funding period to map intercellular
circuits between cardiomyocytes, fibroblasts, and macrophages in non-uniform oxygen environments and
quantify the molecular and functional phenotypes of each cell type. In Aim 1, we will determine the impact of
hypoxic-normoxic crosstalk between cardiac fibroblasts and macrophages on functional and transcriptional
phenotypes, including proliferation, phagocytosis, and migration. In Aim 2, we will determine the impact of
cardiomyocyte-fibroblast-macrophage hypoxic-normoxic crosstalk on cardiac tissue functional and
transcriptional phenotypes. We will measure cardiomyocyte tissue physiology (electrophysiology and
contractility) and use single-cell proteomic technologies to deconvolve cell type-specific secretions and
changes to the proteome. In Aim 3, we will determine the independent and combined impact of an oxygen
gradient and direct contact with fibroblasts and/or macrophages on cardiomyocyte tissue phenotypes. We will
establish technologies to perform spatial RNA sequencing in engineered cardiac tissues comprising
cardiomyocytes, fibroblasts, and macrophages on our oxygen gradient device, which will also enable us to
benchmark our transcriptomic data to published datasets of infarcted myocardium. Our project combines
cutting-edge technologies in tissue engineering and molecular analyses and will lead to new discoveries that
will inform novel therapeutic strategies to mitigate pathological remodeling after myocardial infarction.

Public health relevance
PROJECT NARRATIVE Myocardial infarctions, also known as heart attacks, are one of the most common cardiac injuries worldwide and routinely progress to heart failure for reasons that are not fully understood. In this project, we will advance our engineered “Myocardial Infarct on a Chip” platform to investigate how communication between the three main cell types in the heart is altered by low levels of oxygen, which is a defining feature of a myocardial infarction. We will make new discoveries that can lead to new therapies to improve the health of patients after myocardial infarction.